Determinants of pegivirus persistence and immune control

PROJECT SUMMARY/ABSTRACT
Human pegivirus (HPgV) chronically infects approximately 15% of the global human population. Although HPgV
does not cause overt disease, we know very little about its biology. Currently, there are no cell culture systems
for cultivating HPgV in vitro and no laboratory animals are susceptible to HPgV infection. Recently, we created
the first mouse model of PgV infection by adapting a rat pegivirus to infect mice. This mouse-adapted PgV
(maPgV) causes high-titer viremia in wild-type mice that persists for hundreds of days without causing overt
disease, closely recapitulating key features of HPgV infection. We have also shown that maPgV utilizes a highly
novel, albeit still poorly defined, mechanism of viral persistence. Thus, discovering how PgVs are able to persist
in otherwise immunocompetent hosts could be a useful tool to explore mechanisms of “failed immunity.” Studies
to date have indicated that most wild-type mice are able to exert a degree of anti-viral immunity against maPgV
infection, but this immunity is weak and insufficient to fully eradicate the infection––a phenomenon we call “semi-
control.” In contrast, ~10% of wild-type mice are capable of completely clearing maPgV infection and are immune
to re-challenge––a phenomenon we call “elite control.” Preliminary data suggests that lymphocytes of the
adaptive immune system are responsible for both semi- and elite-control. We will leverage the tractability of the
mouse host to understand both of these phenomena with the ultimate goal of defining differences between semi-
and elite-controllers that govern maPgV persistence. In Aim 1 we will determine adaptive immune functions
responsible for PgV semi-control, using a panel of immune-gene-knockout mice to identify the specific
lymphocyte subsets and effector functions that are responsible for maPgV semi-control and performing
lymphocyte depletion studies at key time points to determine the importance of different lymphocyte populations
for establishment and maintenance of semi-control. We will also introduce a highly immunogenic peptide into
maPgV using reverse genetics, allowing us to track virus-specific immune responses and determine whether
maPgV can “hide” this antigen from the immune system. In Aim 2 we will determine adaptive immune functions
responsible for PgV elite-control, we will passively confer elite control to lymphocyte-deficient mice from elite-
controllers via splenocyte transfer, then break elite control in passively-immunized mice using different
lymphocyte-targeting antibodies to attribute elite control to a specific lymphocyte subset. To determine if a single
lymphocyte population is sufficient to mediate elite control, we will purify lymphocyte subsets from elite controller
spleens and transfer these into maPgV-infected Rag-KO mice. In Aim 3, we will generate tools to quantify anti-
maPgV immune responses in semi-controllers and elite-controllers. Results from these studies will define the
lymphocyte population(s) responsible for various aspects of PgV immunity (and failed immunity), with broader
implications for our understanding of the immune system and the long-term consequences of HPgV infection in
people.

Public health relevance
PROJECT NARRATIVE Approximately 15% of the global human population is chronically infected with human pegivirus (HPgV), yet we know very little about how this virus evades the immune system or the long term impact of chronic HPgV infection on the human host. We have developed a mouse-adapted pegivirus (maPgV) that recapitulates several aspects of HPgV infection including: persistent high-titer viremia; lack of overt disease; and immune-mediated clearance of maPgV infection in a subset (~10%) of individuals. In this project, we will use our maPgV model to study aspects of PgV persistence and immunity, with the ultimate goal of uncovering the novel mechanism by which maPgV evades the immune system and maintains high levels in the blood of infected individuals.